SALMONELLA MUTAGENICITY STUDY USING MULTIPLE DATABASES

The mutagenicity of chemicals is believed to be an important feature towards the chemical causing cancer. At present, there is a limited amount of feasible computational models to estimate the mutagenic potential of new substances. We proposed to develop a new method for predicting mutagenicity by a combination approach of multiple genicity databases using the M-CASE software. The databases will be separated by different Salmonella typhimurium strains and by test conditions. A similar condition model has previously been developed for carcinogenicity as a guide in this mutagenicity study In addition, we have developed a single preliminary database to elucidate the potential of this project. This proposal will outline the carcinogenicity results and estimate the improvement possible for mutagenicity. In addition, we have developed a single preliminary database to elucidate the potential of this project. For the Phase I project, we wish to develop four to six of these mutagenicity modules with the goal of producing a total of 24 mutagenicity databases after Phase II funding. PROPOSED COMMERCIAL APPLICATIONS: The need for pre-emptive determination of mutagenic compounds is immense to the regulatory, environmental and pharmaceutical and pharmaceutical industries. In the regulatory bodies such as the Food and Drug Administration (FDA) and the Environmental Protection Agency (EPA), the ability to quickly and accurately assess a new chemical for potential harmful activity to human or the environment is critical to an effective screening process. The incorporation of this multiple level analysis for mutagenicity as a tool to assist regulators will increase productivity and accuracy of their work. In the pharmaceutical industry, the ability to locate pharmacophores early in the stages of research and development will potentially save massive amounts of time and money for the company. This preventative assessment of mutagenicity of new chemical is clearly important for companies in the environment industry.